Monocytic and exosomal cytochrome P450s in smoking-mediated HIV-1 pathogenesis

Despite the success of antiretroviral therapy (ART), effective treatment outcomes among people with HIV-1 occur
in only 1/3rd of the total HIV-1-population who receives treatment. In addition to reduced adherence to ART
treatment, consumption of substance of abuse including tobacco smoking, which is highly prevalent in people
with HIV-1, is one of the major factors for ineffective treatment outcomes. Smoking is known to exacerbate HIV-
1 pathogenesis in monocytes and macrophages, which serve as sanctuary sites for HIV-1 and infiltrate the brain,
spreading the virus to perivascular macrophages and microglia and causing development of neuroAIDS. It is
difficult to eliminate the virus in macrophages by ART. In addition, smoking accelerates HIV-1 replication, in part
via increased oxidative stress. Our objective is to determine the role of monocytic and plasma exosomal CYP
enzymes in enhancing smoking-mediated HIV-1 replication in smokers. We will accomplish our objective by
testing the hypotheses that: 1) monocytic CYP enzymes mediate enhanced HIV-1 replication in smokers by
contributing to increased oxidative stress and decreased ART efficacy and 2) circulating plasma exosomal CYP
enzymes, secreted from liver and lung cells, are induced in smokers and delivered to macrophages contributing
to enhanced HIV-1 replication. The rationale for the hypothesis is based on literature reports that smoking
exacerbates HIV-1 replication in macrophages. Our own studies suggest that CYP enzymes are induced by
tobacco smoking in monocytes and perhaps in plasma exosomes, and play a critical role in oxidative stress and
ART metabolism in macrophages. We plan to test the hypotheses by determining the: Aim 1: Contribution of
monocytic CYP enzymes in tobacco-enhanced HIV-1 replication in macrophages; Aim 2: Ex vivo validation of
the role of CYP enzymes in smoking-enhanced HIV-1 replication; Aim 3: Contribution of plasma exosomal CYP
enzymes to HIV-1 replication in macrophages. Upon completion of this project, we expect to determine the
mechanistic contributions and gain a new understanding of a novel role of monocytic and plasma exosomal CYP
enzymes in smoking-mediated HIV-1 pathogenesis. Thus, the project would impact the treatment of HIV-1 who
smoke by providing a new target for novel therapeutic interventions, and potential application of exosomes as
therapeutic carriers in effectively treating these patients.

Public health relevance
PROJECT NARRATIVE A critical barrier to progress in improving HIV outcomes in smokers is the lack of understanding of the mechanism by which tobacco smoking decreases the response to antiretroviral therapy and enhances HIV pathogenesis in macrophages, which are sanctuary sites for HIV. Our goal is to improve HIV therapy outcome in smokers by determining the mechanism by which tobacco smoking decreases the response to antiretroviral therapy and enhances HIV. This project will provide the basis for finding potentially novel therapeutic intervention that target monocytic and plasma exosomal cytochrome P450 enzymes.